Feasibility, acceptability, and preliminary efficacy of an adapted group-based and online HIV prevention intervention for immigrant sexual minority men in the US

Project Summary
In 2014, the immigrant population in the United States (US) was 42 million and is projected to reach 78 million
by 2060, a growth of 85%; an estimated 3% of immigrants identify as sexual and gender minorities. Evidence
shows that sexual minority men (SMM) may be particularly likely to immigrate, whether by choice or force, in
search of social and sexual freedoms that are not available in their home countries. Among the general SMM
population, stigma at the individual, interpersonal, and structural levels, and subsequent minority stress reactions
(e.g., internalized stigma, identity concealment, expectations of and actual discrimination experiences) contribute
to co-occurring HIV and mental health risks. Sexual minority stressors negatively influence SMM’s sexual and
mental health, in particular SMM of color. The experiences of Arab immigrant SMM may be different from other
groups, in particular because of their exposure to high structural stigma and potentially lethal homophobia, high
risk to HIV, and poor mental health in their home countries, which then intersects with their current US context
of strong anti-Arab and anti-immigration rhetoric that has intensified in the past 2 decades. Despite this
confluence of risks, there are no interventions that address the magnitude of intersectional stigma on HIV risk
and mental health among Arab immigrant SMM. Theoretically informed interventions can buffer against the
health risks of stigma when tailored to address minority stress reactions among SMM; however, most
interventions do not account for multiple and intersecting sources of stigma, and none focus on immigration-
related stigma, especially as it is experienced by Arab immigrant SMM. Our intervention, ESTEEM (Effective
Skills to Empower Effective Men), a minority stress focused cognitive-behavioral therapy (CBT) has shown
strong efficacy in improving mental, behavioral, and HIV (e.g., condom use and pre-exposure prophylaxis [PrEP])
health outcomes among SMM. Our preliminary interviews with Arab immigrant SMM (N=16) suggest intervention
preferences for an online group delivery format that connects SMM with shared experiences, irrespective of their
current geographical location, thus facilitating greater reach and effective recruitment, to be led by trained
counselors that share similar identities (Arab, immigrant, and/or sexual minority). Following the ADAPT-ITT
model, this study aims to adapt and pilot-test the ESTEEM intervention to target the underlying mechanisms
linking first-generation (i.e. foreign-born) Arab immigrant SMM’s intersectional minority stressors to co-occurring
HIV risks and poor mental health outcomes. In Aim 1, we will seek input from multiple stakeholders using
qualitative interviews with 15 mental health experts and 15 Arab immigrant SMM, and adapt ESTEEM for online
group delivery and for Arab immigrant SMM in the US. In Aim 2, we will randomize 60 participants to receive 10
weekly, 90-minute online-based group sessions, either immediately (immediate intervention group, n=30) or after
3 months (waitlist control group, n=30) to evaluate intervention acceptability and feasibility and to determine
preliminary efficacy on primary (HIV-risk behavior) and secondary (mental health) outcomes.

Public health relevance
Public Relevance Statement The proposed study pilot tests the feasibility, acceptability, and preliminary efficacy of an adapted intervention (ESTEEM) for Arab immigrant sexual minority men in the US to be delivered in an online and group format. Through consultations with mental health experts and Arab immigrant sexual minority men, we will revise the original ESTEEM intervention protocol to address intersectional stigma and minority stress reactions in order to reduce co-occurring HIV risks and poor mental health.